Enabling Technology for Safe Robot-assisted Surgical Micromanipulation

Project Summary / Abstract
The goal of this grant is to develop enabling technology to address fundamental limitations in microsurgery
with a specific focus on developing coordinated bilateral assistance for the vitreoretinal surgeon. Retinal vein
occlusion (RVO) is the second-most-prevalent vision threatening disease of retinal blood vessels, with no
consistently successful clinical treatments to directly resolve the occlusion. A strategic approach, that is
particularly amenable to robotic assistance, is to cannulate the occluded retinal vein with a micro-cannula and to
inject a clot-dissolving agent. Due to human physiological limitations (tremor, tactile perception, visualization,
stress, cognitive requirements, incomplete sensory information, etc.), as well as retinal fragility and the inability
to regenerate retinal tissue, various robotic systems have been developed that target select aspects of retinal
vein cannulation (RVC). However, even with all present and emerging technological advances, a number of
imminently solvable challenges remain as barriers to consistently successful treatment. We propose a bilateral
robotic system with real-time multisensory feedback that assesses multiple points of instrument contact located
both inside and outside of the eye. Our bilateral system will enhance retina and sclera safety, increase the rate
of RVC success, diminish forces on the cannula and vein, reduce the human mental and physical requirements,
and allow the surgeon enhanced motion precision to enable more advanced surgical procedures benefitted by
bilateral manipulation.
To prove the hypothesis that bilateral robot-assisted retinal cannulation is possible and safe, we propose the
following specific aims: (1) Demonstrate coordinated position/force hybrid control algorithms for enabling real-
time sensorimotor capabilities at sclerotomy for safe bilateral robot-assisted vitreoretinal microsurgery: real-time
sensorimotor capabilities at the sclerotomy will be uniquely used to control the robots through a machine learning
method that adaptively learns a nonlinear mapping from user behavior to sclera-force/position and predicts
unsafe motions; (2) Demonstrate position/force-input control algorithms for enabling real-time sensorimotor
capabilities at the tool-tip for safe bilateral robot-assisted vein cannulation: real-time tool-tip-to-tissue interaction
force sensing and non-linear robot control algorithms based on observing user behavior will be used to control
the tool-tip position and force and to prevent entry into subretinal areas during RVC; (3) Demonstrate and
evaluate bilateral RVC using SHER in animal model in vivo: real-time, position/force hybrid control algorithms
based on dual-point (tool-shaft and tip) information fusion will provide sensorimotor guidance of surgical
maneuvers during RVC. Statistically significant results in vivo, in clinically realistic conditions will demonstrate
the feasibility of our approach. This highly innovative system with expanded coordinated bimanual capabilities
will allow us to further increase the safety and reliability of RVC and move the technology to preclinical readiness.

Public health relevance
Project Narrative Retinal vein occlusion is a leading cause of vision loss for which present therapy is limited to incompletely treating the complications of the occluded vein, rather than by directly addressing the causative thrombus. Retinal vein cannulation with precise delivery of therapeutic agent is a very difficult freehand procedure that is well suited to robotic assistance—and potentially best suited for bilateral robotic support. To consistently enable human clearance of obstruction in a retinal vein, we propose to develop a novel bilateral robotic system that will enhance retinal vein cannulation efficiency, success and safety via coordinated bilateral robotic assistance with real-time, multipoint, multisensory feedback.